CORE B: Viral Assays Core

SUMMARY:
Dengue viruses (DENV) are responsible for the most significant mosquito-borne viral disease in humans, causing
over 100 million infections and ~50 million dengue cases annually worldwide. The complexity of the immune
response to four related serotypes (DENV1-4) and lack of reliable correlates of protection have hindered efforts
to develop/improve a safe, effective, and serotype-balanced DENV vaccine. The overall goal of the Program
Project is to delineate the role of adaptive immunity in shaping clinical and immunological endpoints in the context
of DENV natural infection and vaccination. The quality (antibody [Ab] breadth, diversity, and function) of humoral
immune responses underpins the outcomes (protection or enhancement) of subsequent DENV infection. The
Viruses and Assays Core B develops and provides advanced virological tools for high-throughput, sample-
sparing platforms to comprehensively characterize the humoral immune profile of serum samples and
monoclonal antibodies (mAbs) from Project 1, Project 2, Clinical, Data, Statistical Modelling Core C, and
Antibodyomics Core D. Core B builds upon the state-of-the-art DENV reverse genetics system developed over
the historical course of this program by the Baric laboratory (University of North Carolina, Chapel Hill). The key
reagents and tools include DENV serotype and genotype panels, DENV chimeric domain swap panels, DENV
Ab epitope removal and resurfacing panels, and DENV NanoLuc reporter panels. Additionally, a reagent-sparing,
high-throughput NanoLuc reporter neutralization assay has been developed and is ready for deployment across
the program. A novel assay has also been developed and tested that specifically measures the fraction of a
serum response that encodes enhancing antibodies. The Tse Laboratory (St. Louis University), with expertise in
saturation mutagenesis, will develop a Deep Mutational Scanning (DMS) platform for unbiased, high-throughput
monoclonal antibody mapping and to dissect complex serum fingerprints with embedded epitope information for
individual subjects. Thus, Core B will provide assays, reagents, and protocols to measure Ab binding profiles
and neutralizing and enhancing Ab titers of selected sera for Project 1 and Project 2 as well as support
hypothesis-driven questions about immune imprinting in DENV infection, vaccination, sequence of infection, and
other relevant parameters. In collaboration with Core C, Core B will generate new antigenic cartography serum-
antigen maps reflecting the endemic strains of the cohorts in Nicaragua (Project 1) and the Philippines (Project
2) and the NIH vaccine challenge study (Core C). These tools will be used to create serum signatures from
longitudinal samples with unprecedented resolution to understand immunological imprinting for DENV infection.

Public health relevance
NARRATIVE: The incomplete understanding of complex dengue virus humoral immune responses and their effect on dengue pathogenesis contributes to controversial public health decisions and vaccine deployments. Core B provides P01 program-wide support by developing state-of-the-art methodologies to deconvolute complex serum profiles from dengue virus infections and vaccinees to translate serological information into useful epidemiological parameters associated with protective or enhancing immunity. These new reagents and assays are designed to test key Project-generated hypotheses, identify domain- and epitope-specific neutralizing antibody responses, and generate single amino acid antibody/serum profiles that support high resolution antigenic cartography.